MDSRC Administrative Core

Abstract
The Center for Gene Therapy at the Abigail Wexner Research Institute of Nationwide Children’s
Hospital (NCH) and the OSU/NCH Center for Muscle Health and Neuromuscular Disease
comprise a robust and active research community in the muscular dystrophies, with a particular
longstanding interest in developing meaningful therapies for the most common forms, including
Duchenne muscular dystrophy (DMD). We have extensive expertise in unraveling disease
pathogenesis and developing new treatment paradigms that can be translated from the bench to
the bedside. We propose an MDSRC with Cores designed to share this expertise with the
Wellstone Network and broader muscular dystrophy research communities, with Projects
intended to advance therapies beyond current, very promising prospective therapies, such as
microdystrophin gene therapy. Project 1 (PI, Paul Martin, PhD) seeks to utilize a novel bicistronic
AAV vector to both prevent muscle disease and simultaneously build new muscle function in
muscular dystrophy with Limb Girdle Muscular Dystrophy 2I (LGMD2I). Project 2 (PI, Kevin
Flanigan, MD) will develop vectors containing U7 small nuclear RNAs (U7snRNAs)
reprogrammed with antisense sequences directed toward splice site or splice enhance elements
to restores expression of a highly functional dystrophin, and to characterize two novel mouse
models relevant to clinical development. Project 3 (PI, Nizar Saad, PhD) seeks to identify novel
circulating biomarkers through the investigation of circulating extracellular vesicles (EVs) and to
develop a new generations of gene therapy that increase transduction efficiency, dystrophin
expression, and reduce the development of humoral immunity against AAV gene therapies. All
three projects make use of the critical resource core, the Muscular Dystrophy Cell and Serum
Banking Core (Director, Nicolas Wein, PhD) by establishing primary fibroblasts from patients with
muscular dystrophies, a critical resource for early therapy development, while collaborating with
Penny Gilbert, PhD, at the University of Toronto, to develop improved protocols leading to
superior reagents for Center Projects. We have a longstanding dedication to serving as a national
training resource, as demonstrated by our Myology Course, held annually since 2012, and our
Training Core (Director, Scott Harper, PhD) will expand the number of attendees and the range
of topics covered in the Course, offer individualized career development guidance to Wellstone
Fellowship trainees, and develop new curricula of benefit to the community. Our Administrative
Core will implement a meaningful community outreach program and develop a highly functional
MDSRC website to provide access to the muscular dystrophy community. Altogether, our
longstanding efforts and the highly collaborative multidisciplinary environment of our two
institutions will be synergized by a MDSRC that leverages existing structures and collaborations
and develops outward-facing resources of benefit to the broader Wellstone and muscular
dystrophy research communities.